Role of Macrophage in Osteoimmunology with Aging

Project Summary/Abstract
T helper cells (Th1 and Th17) play an important role in bone homeostasis through regulating osteoclast (OC)
formation in autoimmune diseases and OVX-induced osteoporosis. However, how these T cells interactions
with bone cells disrupt bone homeostasis during aging to cause bone loss in age-related osteoporosis
(AROP) remains poorly understood. We reported that TGFβ1 (Tβ1) is a major bone loss-causing cytokine in
AROP. It induces lysosomal degradation of TRAF3, a receptor adaptor protein that negatively regulates NF-κB
activation, in mesenchymal progenitor cells (MPCs) to directly inhibit bone formation. However, the release of
active Tβ1 from resorbing bone is limited because of low bone turnover in AROP. We have identified a novel
subset of CD11b+F4/80+Ly6ChiLy6G- macrophages expressing membrane-bound Tβ1 (mbTβ1), which we call
MbTβ1Macs, whose numbers are increased in the bone marrow (BM) of aged mice. MbTβ1Macs also express
ITGB8 which can directly activate mTβ1. MbTβ1Macs have less potential to form OCs, but significantly inhibit
osteoblast (OB) differentiation. Th1 cells expressing IFN-γ and senescent/immune checkpoint PD-1 are also
increased in the BM of aged mice. IFN-γ induces Ly6Chi macrophages to express mbTβ1, which in turn
stimulates Th1 cells producing IFN-γ and PD-1 in vitro, associated with reduced levels of TRAF3. These effects
are blocked by the FDA approved lysosomal inhibitor, hydroxychloroquine (HCQ). Our proposed studies will 1)
determine if ITGB8 activates mbTβ1 in MbTβ1Macs to inhibit bone formation during aging; 2) determine if IFN-
γ polarizes MbTβ1Macs, which in turn promote Th1 cell senescence with enhanced production of inflammatory
factors via Tβ1 induction of TRAF3 lysosomal degradation in aged mice; and 3) evaluate if our recently
patented bone-targeted HCQ, with dual anti-resorptive and anabolic effects in an OVX-induced osteoporotic
model, can prevent and treat AROP and low level chronic inflammation during age by blocking the reciprocal
interactions between macrophages and Th1 cells. Completion of the proposed studies will identify novel
mechanisms to explain the disruption of bone homeostasis during aging through reciprocal interactions
between macrophages and Th1 cells, in which this novel subset of macrophages inhibits bone formation and
causes BM low-level chronic inflammation by stimulating Th1 cells to produce inflammatory factors.
Importantly, it will provide proof of principle that a bone-targeted HCQ may be a novel treatment for AROP.

Public health relevance
Project Narrative We have identified a new subset of macrophages, which express TGFβ1 on their cell surfaces and are present in high numbers in the bone marrow of aged mice where they appear to inhibit bone formation and interact with T lymphocytes to cause low level chronic inflammation during aging. We plan to further investigate the molecular mechanisms whereby interactions between these macrophages and T lymphocytes cause bone loss and low level chronic inflammation in aging mice and to determine if our recently patented bone-targeted hydroxychloroquine can block these interactions to prevent and reverse age-related osteoporosis.